A commercialized platform for diversified large-scale chronic electrophysiology

PROJECT SUMMARY
Chronic multichannel electrophysiology is a critical tool for examining how behavior arises from
the complex interconnected activity of the brain. The goal of this project is to provide a commercial
ecosystem for multi-electrode array (MEA) manufacturers to scale their products to many more
electrodes than they currently offer. By commercializing a compact 512-channel integrated
circuit—the EChip—we will offer a path for MEA manufacturers to integrate electronics directly
onto their arrays, thereby sidestepping the need for bulky connectors or electronics. We aim to
enable the availability of diverse types of electrodes, all with increased channel counts, to satisfy
the diverse needs of experimenters. Furthermore, by developing versatile electronics and
powerful software to interface with the EChips, the EChip-enabled MEAs will be usable in diverse
behavioral paradigms and species.

Public health relevance
This project aims to develop and commercialize an integrated circuit that can amplify and digitize 512 concurrent neural signals from multi-channel electrode arrays. Furthermore, we aim to develop and commercialize electronics that control multiple EChips at once and log the data to an SD card, offering a way to scale channel counts to above 2000 without the need for cables between the animal and a computer.